VARIABILITY OUTCOME OF RENAL TRANSPLANT TREATED WITH SANDIMMUNE VS. NEORAL

Determine the intra-patient varibility in cyclosporine pharmacokinetics of stable renal transplant patients treated with Sandimmune and then converted to Neoral as primary immunosuppressive therapy and to exam the relationship of varibility in cyclosporine pharmacokinetic on outcome. We continuing our efforts in recruitment and enrolling.